Multiomic analysis of downstream molecular effect of teloemre length in individual chromosome arms

PROJECT SUMMARY
Healthy human cells contain 92 telomeres (2 arms per 46 chromosomes), each with unique lengths that
shorten during cell division, and that protect the genome from enzymatic degradation. Average telomere length
(TL) of all 92 telomeric alleles has clinical relevance as a biomarker for cellular aging and a broad variety of
health-related conditions, including telomere biology disorders (TBD): inherited disorders that exhibiting
idiopathic pulmonary and liver fibrosis, bone marrow failure and cancer predisposition. Telomeres also play an
important regulatory role in gene expression through the telomere position effect (TPE). However, the clinical
relevance of these individual 92 chromosome arm-specific TLs and their connection with TPE is still unclear.
None of the existing methods to measure TL are at the same time accurate, scalable, suited for any tissue
source, or able to provide length of individual telomeres. This includes Flow-cytometry Fluorescence In-Situ
Hybridization (flowFISH), the only CAP/CLIA-approved test to measure TL. Recent advances in long-read
sequencing technologies have allowed our group to develop Telogator, a novel bioinformatics approach that
estimates TL for all 92 alleles, individually, from this data. We propose to use this approach in combination with
multiomics analyses to test the main hypothesis that individual chromosome arm-specific TL are clinically
relevant in the diagnosis and understanding of TBD, and that individual shortened telomeres can trigger
transcriptomic and epigenomic changes involved in the pathogenesis of the disease. Through the Mayo Clinic
TBD Specialty Clinic, we have managed over 150 patients with manifestations of TBD including flowFISH and
genetic germline testing. These individuals are clinically and molecularly annotated, they have already given
consent for research through our IRB-approved protocol and PBMC samples are readily available. We will use
this unique resource to test our hypothesis by completing the following aims: In Aim 1 we will define the
reference TL values at the chromosome arm level across the lifespan of healthy individuals using our novel
sequencing-based bioinformatic tool (Telogator) on 30 individuals distributed in age decades from their 20s to
their 70s. We will then compare these reference values with the length of individual telomeres from TBD
patients (n=30) calculated using the same approach. In Aim 2 we will characterize the transcriptomic (RNAseq)
and epigenomic (ChIP-seq) changes in correlation to the TL of each individual chromosome arm to describe
genes regulation through TPE in the context of TBD. This project will explore the conceptually innovative idea
that TL of individual chromosome arms has clinical significance and can exert characteristic epigenomic and
transcriptomic changes in human cells. Our research will translate into better diagnostic tools for TBD and
pave the way for future research in the pathogenesis of the disease. Understanding the gene regulation related
to chromosome-specific TL will facilitate the study of other telomere-related processes like aging and cancer.

Public health relevance
PROJECT NARRATIVE The length of telomeres, structures at both ends of each chromosome, is a relevant clinical biomarker for aging, cancer, and telomere biology disorders. Most current telomere measurement methods only provide the average of all 92 telomeres present in the human genome, which is not representative of the individual telomeres variability and has impaired our capacity to study telomere biology. Our research will use a new approach (Telogator) to measure each of the 92 telomeres independently using long-read genome sequencing data and will describe the downstream molecular effect and clinical implications exerted by length changes in a single telomere basis, paving the way for future research in all telomere-related fields.